TOPIC 435 - PHYSIOLOGICAL COMPRESSION THERAPY TO AUGMENT LYMPHATIC FUNCTION AND IMPROVE LYMPHEDEMA RESOLUTION.

LymphaTech seeks to develop a novel lymphatic physiology-based, feedback-controlled intermittent pneumatic
compression (IPC) device for the treatment of secondary lymphedema. While compression therapy has been the primary
treatment for lymphedema patients for decades, there have been minimal innovations in approaches that leverage
compression therapy. In contrast to this, there have been substantial gains in understanding of lymphatic physiology and
lymphedema disease progression that have not been realized into innovative approaches to improve compression for
lymphedema. This Phase 1 proposal aims to develop a prototype that drastically improves medical compression therapy
through the major innovations: 1) the incorporation of dynamic external pressure waveforms with magnitudes and
temporal and spatial frequencies that are optimized to enhance lymphatic contraction of the lymphatic pump; 2) realtime
monitoring of tissue bioimpedance using novel flexible, wearable sensors to provide feedback of tissue water
content to compression protocols for optimization of compression based on patient activity (e.g. sleeping, standing,
sitting); and 3) incorporation of LymphaTech’s proprietary compression garment sizing and limb measurement volume
technology to further enhance compression efficacy. Optimizing the delivery of lymphatic physiology-based compression
waveforms combined with real-time feedback from embedded sensors is expected to dramatically increase the clinical
efficacy of IPC for lymphedema patients.